A Deep Learning-based Assessment Pipeline for Peripherally Inserted Central Catheters (PICCs) on Pediatric Radiographs

Project summary:
Peripherally inserted central catheters (PICCs) have become an integral part of the complex intensive care
of critically ill patients in pediatric intensive care units (ICUs). Unfortunately, PICC malposition occurs in
approximately 3.6%-5.6% of pediatric patients. It is critically important to frequently assess the position of PICCs,
because malpositioned PICCs can lead to a variety of clinical complications, such as thrombosis, cardiac
arrhythmia, and inadequate therapy. Chest X-rays (CXRs) are widely used radiographic images for the periodic
assessment of PICCs in children. However, assessing PICCs is a labor-intensive, time-intensive task for
radiologists. Prior studies have demonstrated the promise of deep learning for automated PICC assessment in
adult patients. To date, there are no available methods for pediatric PICC assessment. An accurate, robust, and
clinically available tool that can automatically assess PICCs in pediatric CXRs is a critical unmet need.
The objective of this proposal is to develop an automated PICC assessment pipeline for pediatric CXRs using
deep learning algorithms. To accomplish our objective, we will leverage ~4,000 retrospectively collected CXRs
from pediatric ICUs. In the current clinical assessment of PICCs using CXRs, radiologists would typically (1)
identify each PICC line, (2) locate the ideal PICC landing zone, and (3) determine whether the distal tip of the
PICC is appropriately positioned within the landing zone. By closely mimicking radiologists, we design a novel,
transparent, and interpretable three-component PICC assessment pipeline. Specifically, we propose to (Aim 1)
develop a topology-preserving deep learning method to segment PICCs, (Aim 2) develop a landmark detection
method to locate the ideal PICC landing zone, and (Aim 3) assemble the pipeline and evaluate its performance
in detecting PICC malposition using CXRs in pediatric patients.
This project is highly impactful to clinical practice. Assessment of PICCs commonly occurs within a procedure
called Lines, Drains, and Airways (LDAs) reconciliation, in which radiologists review LDA intensive care devices
on CXRs and communicate with intensive care physicians in ICUs to ensure safe patient care. Our proposed
pipeline will promote LDA reconciliation between radiologists and intensive care physicians. By taking timely
remedies, physicians in ICUs can quickly reposition those malpositioned PICCs back to the ideal landing zone,
thereby mitigating potential risks of major clinical complications. Once validated, our pipeline can also be
extended to other LDA devices, such as endotracheal tubes or chest tubes. The resulting models will be made
available to the community for both research and clinical purposes.

Public health relevance
Project Narrative: Peripherally inserted central catheters (PICCs) have become an important part of clinical care for critically ill children in pediatric intensive care units (ICUs). Unfortunately, improper positioning of the PICCs occurs in approximately 3.6%-5.6% of pediatric patients. Thus, it is critically important to frequently assess the position of PICCs. Chest X-rays (CXRs) are widely used radiographic images for the periodic assessment of PICCs in children. However, assessing PICCs is a labor-intensive, time-intensive task for radiologists. Herein, we propose to use artificial intelligence/deep learning techniques to automatically assess PICCs on CXRs from pediatric patients. This will allow intensive care physicians to take timely remedies to reposition those improperly positioned PICCs, thereby mitigating the potential risk of major clinical complications.